Roles of Chromatin Modification in BRCA1 Dependent DNA Repair

Contact PD/PI: Greenberg, Roger A.
Summary
Encounters between DNA replication proteins (replisome) and specific genomic lesions invoke requirements
for BRCA1 and BRCA2 (BRCA) dependent repair by homologous recombination (HR). Replisome conflicts
with endogenous DNA damage also elicit error prone homology directed repair (HDR) mechanisms and
damage tolerance pathways that allow replication through persistent genomic lesions. Such noncanonical HDR
pathways become prominent in BRCA mutated cells. They are also responsible for telomere maintenance in
~15% of human cancers that utilize the alternative lengthening of telomeres (ALT) mechanism. We have
developed unique systems to investigate the endogenous lesions that provoke BRCA dependent and
independent HDR and have used them to understand how each repair mechanism is initiated and resolved. In
the current R01 funding period, we have demonstrated that (1) loss of the PAR dependent chromatin
remodeler, ALC1, potentiates PARP inhibitor responses by several orders of magnitude specifically in HR
deficient cells, (2) Break induced replication utilizes PCNA-Ub interaction with SNM1A for resection dependent
template switch recombination bypass of polymerase blocking lesions, and (3) BLM helicase activity generates
single-strand DNA at replicating telomeres to promote a damage response that executes ALT. The proposed
research investigates the biochemical basis for these phenomena, and how they process specific endogenous
DNA lesions to provoke either classical or alternative forms of recombination. We utilize approaches to identify
the full spectrum of responses that occur at damaged telomeres and interrogate specific DNA replication
associated structures that ALC1, SNM1A, and BLM act upon to affect repair mechanism. Overlapping genetic
vulnerabilities in ALT and BRCA mutant cells suggest commonality in the repair processes that ensue in each
scenario. Our overarching goals are to delineate molecular events necessary for each process and understand
how classical and alternative mechanisms of homologous recombination intersect in the settings of (1) BRCA
mutation, and (2) during ALT. These objectives will be performed in parallel and with equal emphasis. Our
studies will yield fundamental advances to the understanding cancer genome integrity control.

Public health relevance
Narrative My research program is devoted to understanding fundamental mechanisms of genome integrity control and how they impact cancer etiology and response to therapy. We will continue to approach these central questions in cancer biology by utilizing unique systems that we have developed to investigate the molecular basis underlying (1) DNA damage recognition, (2) genomic lesions that activate classical and alternative forms of homology directed DNA repair, and (3) response to targeted agents. These pursuits will provide invaluable insights into cancers that arise as a consequence of altered usage of DNA repair pathways, and their adaptive responses to DNA damaging therapies.